Modernization of Anatomical Modeling Capabilities at UC Davis Core Facility

Project Abstract
The Translating Engineering Advances to Medicine (TEAM) Lab, a core facility within the Biomedical
Engineering Department at the University of California, Davis, seeks support to acquire the Stratasys J5 Digital
Anatomy 3D Printer to modernize our shared-use biomedical research facility and overcome current limitations
in the university's 3D printing technologies. The J5 Digital Anatomy Printer offers unique capabilities, including
the ability to incorporate multiple materials into a single print to replicate the biomechanical properties and
radiopacity of human tissue. Its advanced software comes pre-programmed with clinically validated presets
that mimic a range of human tissues, while also allowing precise control over material composition and
microstructures to replicate various tissue pathologies.
By enhancing our ability to produce realistic anatomical models, the J5 printer will significantly elevate our
research capabilities across multiple disciplines. It will facilitate groundbreaking studies in medical device
development, surgical planning for rare and difficult-to-treat conditions, optimization of radiation dose delivery
treatments, and more. Moreover, the ability to 3D print identical replicas of pathologies allows for more precise
experimental testing and controls, reducing reliance on cadaver and animal models, which are costly, difficult
to source, and generate biological waste.
Acquiring the Stratasys J5 will enable the TEAM Lab to support new research initiatives currently constrained
by technological limitations. By providing advanced simulations and realistic models, the printer will drive the
development of new treatments for challenging disease states, leading to better patient care and outcomes.
This enhancement aligns with UC Davis's mission to advance public health through pioneering research and
innovation, ultimately fostering improved healthcare solutions and societal well-being.
We plan to integrate the equipment into the TEAM Lab expansion, located at the UC Davis Sacramento
Campus, is fully prepared for the new printer without requiring any site modifications. This expansion
demonstrates the department’s and university's continued support for the TEAM Lab, operational since 2010
under the proposed PI’s management.

Public health relevance
Project Narrative The acquisition of the Stratasys J5 Digital Anatomy 3D Printer will enhance biomedical research capabilities at UC Davis by enabling researchers to utilize biomechanically accurate, highly realistic anatomical models tailored to their specific needs. By improving the models used in medical device development, surgical planning, and treatment optimization, this equipment will contribute to better patient outcomes and advance public health through enhanced research innovation and clinical safety.